RFA-CE-23-004: Structural factors Impacting community Violence (STRIVE): The Role of Minimum Wage, COVID-19, and Discrimination

ABSTRACT: Violent deaths are responsible for the most person-years of life lost among people 18 to 50 years
old in the United States. Further, violence inflicts a disproportionate burden on racial and ethnic minorities in
the US, thereby exacerbating existing health inequities, including those amplified by COVID-19. Although the
physical distancing policies put in place to address the COVID-19 pandemic reduced social interactions,
violence-related injury and homicides increased in 2020 in the US. Structural and policy interventions that
target the social-ecological framework can attain sustainable reductions in multiple forms of violence. Given
that poverty is one of the drivers of violence, increasing minimum wage may be a potent policy intervention for
violence prevention. However, minimum wage increase laws have not been evaluated as a community
violence prevention method. Further, several states increased minimum wage during 2020 and 2021, providing
a unique opportunity to examine whether such increases can prevent community violence during the
pandemic. Our study will address three important questions: 1) what role do minimum wage increases play in
community violence prevention? 2) Does minimum wage increase or lack thereof differentially affect
community violence among different demographic groups (race/ethnicity, sex, age, and rurality)? and 3) how
has the COVID-19 pandemic impacted community violence and if state minimum wage (SMW) increases and
economic impact payments (EIP) played a role in mitigating pandemic effects? To address these research
gaps, our team will employ rigorous quasi-experimental designs (synthetic controls and controlled interrupted
time series) with quantitative bias analyses, on six national datasets from 2000-2021 to capture community
violence victimizations, assault injuries, and homicide deaths in all 50 states. We will then examine the
interaction of minimum wage with income inequality measured using living wage. We will estimate the impacts
of the COVID-19 pandemic itself, and the impact of state level increases in minimum wage during the
pandemic on community violence outcomes. Through all these analyses we will examine disparities by race,
sex, age, and rurality. This study is responsive to the RFA-CE-23-004's funding objective three to evaluate
approaches that improve social or structural contributions that contribute to community violence and
racial/ethnic inequities. This study will be the first to comprehensively assess the impact of minimum wage
increases on violent victimizations, injuries, and homicide deaths and the racial, sex- and age-based, and
geographical disparities therein. Further, this study will also be the first to examine how SMW increases and
EIPs may have moderated the impact of COVID-19 pandemic on community violence in the US. We will
employ state-of-the-art epidemiologic methods to build a strong evidence base to control and reduce the
burden of community violence in the US. Understanding the impact of SMW increases, which greatly affect
racialized minorities and women, will also provide guidance to reduce systemic inequities.

Public health relevance
PROJECT NARRATIVE This study will generate robust evidence for the impact of minimum wage increases on community violence victimization (including robberies, sexual assaults, and IPV victimization), assault injuries, and homicide deaths; will evaluate how minimum wage increases impacted community violence; will assess how the COVID- 19 pandemic affected community violence and is potentially moderated by economic impact payments; will examine the racial/ethnic, gender, age, and geographic disparities among these associations; and will evaluate the joint impact of the COVD-19 pandemic and minimum wage increases on community violence.